Psychiatric Epidemiology Training Program

Mental disorders are among the leading causes of disability in the world, and improved strategies
to reduce their burden are needed. Epidemiologic studies of psychiatric disorders now include not
only important quantification of prevalence and incidence, but also sophisticated measures of
phenotype, high-throughput -omics assays, etiologic inquiry, and broad prevention interventions.
Neuroscience, via increasingly accessible imaging modalities collected in large numbers of study
participants, has only begun to inform public health. In tandem, long-term health impacts of mental
disorders, including suicide, have continued to increase in prevalence despite best efforts at
prevention and mitigation. The goal of the Psychiatric Epidemiology Training (PET) program at the
Johns Hopkins Bloomberg School of Public Health is to produce the next generation of psychiatric
epidemiologists who can address these needs by conducting research that will advance our
understanding of the causes and consequences of mental disorders, and developing,
implementing, and evaluating rationally designed interventions to prevent and/or control these
disorders. It will achieve this through a rigorous program of coursework, research apprenticeships,
and integrative activities that provide trainees with a solid foundation in the core proficiencies of
psychiatric epidemiology while giving them the opportunity to pursue specialized training in one of
two Concentrations: Etiology of Mental Disorders and Interventions in Mental Disorders. The
program will include 6 predoctoral fellows who are supported by an experienced group of 24 Core
and 12 Affiliate Faculty who are aligned with one of the two Concentrations. PET program trainees
will be prepared to assume leadership positions in mental health research as faculty in Schools of
Public Health or Medicine, in government positions formulating research priorities and mental
health policy, in private industry conducting applied research, or in non-profit mental health
agencies or non-governmental organizations advocating for those with mental disorders. The PET
program has successfully trained psychiatric epidemiologists for over 4 decades. Drs. Volk and
Zandi will continue to lead the program and build on the successes of the last cycle to train the
next generation of leaders in psychiatric epidemiology. They are poised to continue building on the
rich tradition of the program and lead it in new directions that will produce leaders in psychiatric
epidemiology who will advance the field and drive research that focuses on etiologic mechanisms
and targeted interventions.

Public health relevance
PROJECT NARRATIVE This training program is motivated by the fact that mental disorders are among the leading causes of disability in the world, and improved strategies to reduce their burden are needed. The goal of this training program is to produce the next generation of psychiatric epidemiologists who can address this need by conducting research that will advance our understanding of the causes and consequences of mental disorders, and developing, implementing, and evaluating rationally designed interventions to prevent and/or control these disorders.